REGULATION OF HDL LEVELS BY GENETIC AND ENVIRONMENTAL FACTORS

Patients screened for HDL cholesterol, apo A-I and A-II levels. HDL turnover assessed in vivo to determine synthetic and catabolic rate of HDL apolipoproteins. Gel electrophoresis, immunoblotting and mass spectrometry to assess apolipoprotein and lipoprotein lipase structure with molecular DNA analysis where indicated. Nutritional perturbations of HDL metabolism assessed by restudying patients on a low fat diet and alcohol intake.